200 kV Field Emission Gun Transmission Electron Microscope for Cryo-electron Microscopy

PROJECT SUMMARY Recent advances in microscopes, detectors and computational image processing have revolutionized structural analysis of biological macromolecules by cryo-electron microscopy (cryo-EM). These advances are allowing researchers to generate atomic models of biomedically relevant molecules that are refractory to other structural techniques. The University of California at Santa Cruz hosts several NIH-funded structural biology researchers who are advancing studies of complex cellular machineries including the ribosome, spliceosome, telomerase, cell-cycle regulators, circadian clock, childhood viruses, immune response regulators and amyloidogenic polypeptides. Cryo-EM holds huge promise to advance our research programs, but we need to update and expand our local capabilities to bring new structural studies to fruition. We request funding for a 200 kV transmission electron microscope with a direct electron detector, and bundled with an automated plunge freezer. The instrument will replace an aging 120 kV instrument with limited cryo-EM capabilities and an obsolete operating system. A 200 kV instrument designed for cryo-EM data collection will allow a talented group of structural biologists to realize the promise of cryo-EM to determine the structures of larger and more challenging complexes of proteins and nucleic acids and reveal the molecular basis of a variety of human diseases. The instrumentation will also complement our membership in a consortium of our sister institutions in the San Francisco Bay Area, which gives us access to the most advanced cryo-EM instrumentation to push the structures that we first solve at UC Santa Cruz to the highest resolution possible.

Public health relevance
PROJECT NARRATIVE Advances in cryo-electron microscopy have opened the door to determining the structure and function of the complex assemblies of proteins and nucleic acids that drive cellular function and underlie many humans diseases. We seek funding to update an aging facility with a new cryo- electron microscope, which will allow a large community of structural biologists to develop existing and new projects that exploit the exciting potential of the technology.